CP 424 391 IN MEN &WOMEN W/ MILD TO MODERATE HEART FAILURE

This study is being done in order to determine safety and potential beneficial effects of a new investigational drug, CP-424,391, in patients with congestive heart failure. CP-424,391 may have value for the treatment of congestive heart failure by causing increased release of a natural hormone in the body, growth hormone. Increasing growth hormone levels could improve the pumping of the heart and thus help the condition. This study will be the first use of CP-424,391 in patients with congestive heart failure. Because this is a research study, CP-424,391 will be available to the patient only during their participation in this study and not after.